Chikungunya Recombinant Subunit Vaccine

7. Project Summary/Abstract
Chikungunya virus (CHIKV) is an alphavirus of the Togaviridae family that causes fever, rash, and arthralgia
in humans, leading to debilitating illness and poor quality of life. In the past 20 years, CHIKV has greatly
expanded its geographic distribution in part due to climate changes as well as its adaptation to Aedes
albopictus mosquitoes and remains a global health threat due to its high rate of infectivity and the severity of
disease it causes. Estimates indicate that over 1.3 billion people reside in areas at risk for CHIKV
transmission, with over 114,181 cases and 43 deaths reported to date in 2023 alone. Despite CHIKV’s
classification as a category C priority pathogen and its recent identification as a prototype pathogen for NIAID’s
Plan for Pandemic Preparedness, there are currently no licensed vaccines or therapeutics to protect against
CHIKV infection. While a few vaccine candidates have progressed to advanced stages of development,
manufacturing challenges exist for complex vaccine compositions for enveloped viruses. This is compounded
by an incomplete understanding of virally-induced chronic CHIKV disease mechanisms that can introduce
adverse event risks, especially for replication-competent vaccines. Alternate vaccines utilizing methods that
can offer better safety profiles as well as benefits in manufacturing are warranted. We have developed a
promising recombinant subunit CHIKV vaccine that induces high levels of neutralizing antibodies, prevents
viral replication in immunocompetent mice and protects immunocompromised mice from lethal challenge. The
role of antibodies in protection was demonstrated in a passive transfer study where immune sera was injected
into naïve immunocompromised mice and full protection was achieved after lethal virus challenge. The overall
goal of the current Phase IIB renewal research is to support preclinical efforts to further advance the CHIKV
E2/E1 recombinant subunit vaccine candidate formulated with the next-generation adjuvant SLA-LSQ. These
efforts will enable human clinical trial evaluation and further the potential for commercialization. The proposed
research aims to 1) Evaluate the E2/E1 vaccine in chronic disease and durability studies; 2) Prepare cGMP
lots of E2/E1 vaccine antigen; 3) Submit a pre-IND package to FDA for review and conduct a rabbit toxicology
study; and 4) Prepare and submit IND to the FDA. Completion of the proposed work will promote the clinical
advancement of a safe and stable vaccine alternative using an established recombinant protein manufacturing
platform that can combat the significant disease threat posed by CHIKV.

Public health relevance
8. Project Narrative The proposed research focuses on the further advancement of a candidate vaccine that protects against chikungunya virus (CHIKV) which causes debilitating disease in humans. The vaccine is based on an established recombinant subunit platform for producing viral envelope proteins. Although CHIKV is not yet prevalent in the U.S., recent epidemics in the Americas provide the potential for the virus to become endemic in the U.S. and its territories. CHIKV is classified as a category C priority pathogen and has been identified as a prototype pathogen for the Togaviridae family of viruses in NIAID’s Pandemic Preparedness Plan. A successful CHIKV vaccine would also streamline the rapid development of vaccines for other Togaviruses with pandemic potential.